RO 24-7429 (TAT INHIBITOR) ORAL SOLUTION IN HIV ASYMPTOMATIC VOLUNTEERS

The HIV genome contains a number of genes that regulate viral replication. The TAT inhibitor RO24-7429 is the first compound for clinical testing which can control the activity of these genes and their encoded proteins.